Resistance exercise for protection against glucocorticoids in aged skeletal muscle

Project Summary/Abstract
Glucocorticoid myopathy is the most common noninflammatory myopathy affecting ~60% of those with
elevated glucocorticoids. Glucocorticoid myopathy is diagnosed by muscle atrophy and weakness; however,
the myopathy includes other symptoms such as insulin resistance. The elderly are particularly vulnerable to the
myopathy as aged muscle is more sensitive to glucocorticoids, endogenous glucocorticoid levels are increased
more than 50% in the elderly, and therapeutic glucocorticoids that treat conditions like arthritis and cancer are
most prevalent in the elderly. While it is known that glucocorticoid myopathy is most prevalent in the elderly,
there are a lack of treatments to prevent the myopathy in this highly vulnerable population. Our recent
publication suggests resistance exercise could be an immediate way to protect aged muscle from
glucocorticoid myopathy. Specifically, we show that a bout of resistance exercise in young muscle reduces
nuclear translocation of the glucocorticoid receptor, a critical step in the process by which glucocorticoids
initiate myopathy. The ability of resistance exercise to blunt nuclear translocation by is particularly important for
the elderly because activation of the receptor induces a more severe myopathy in aged muscle. Also important
for the elderly population, we show that receptor translocation is reduced in the post exercise recovery period,
suggesting that a single bout of resistance exercise could have a lasting protective effect against
glucocorticoids. A muscle targeted approach like resistance exercise will also allow elderly patients taking
prescription glucocorticoids to keep getting therapeutic benefits of the hormone in non-muscle tissue (e.g.
cancerous tumor). In extension of that work, our preliminary data show that a bout of resistance exercise can
prevent the glucocorticoid-induced change in the expression of some target genes, while others appear
resistant to the exercise stimulus. Because the elderly are so vulnerable to glucocorticoid myopathy, and
because glucocorticoids influence expression of up to 20% of the genome, it is important to understand the
capacity of resistance exercise to blunt the signals that initiate glucocorticoid myopathy in aged muscle so that
clinicians can clinicians more effectively treat these elderly patients. Thus, the objective of this proposal is to
define the therapeutic potential of resistance exercise to mitigate processes that initiate glucocorticoid
myopathy in aged skeletal muscle. SPECIFIC AIM 1 will Define the steps within the glucocorticoid receptor
activation process where resistance exercise imparts disruption in young and aged muscle. SPECIFIC AIM 2
will classify and characterize the glucocorticoid target genes in young and aged muscle based upon how a
bout of resistance exercise affects hormone-regulated gene expression. This pilot study will define the extent
to which resistance exercise can blunt the signals that initiate glucocorticoid myopathy in aged skeletal muscle.
These outcomes are significant because they will provide key information for clinicians to effectively use
resistance exercise as part of a comprehensive strategy to prevent glucocorticoid myopathy in the elderly.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will define the ability of resistance exercise to mitigate the signals that initiate glucocorticoid myopathy in aged muscle. This knowledge will ultimately help clinicians more effectively treat glucocorticoid myopathy in aged individuals. The proposed research is relevant to the NIH’s mission that pertains to seek fundamental knowledge about living systems and the application of that knowledge to enhance health, lengthen life, and reduce disability.